MCSP TORFP NO. NIH-NINDS-21-01: FLORIO (ANAGIN) - BASE EC (STROKE)

The Contractor, in performance of work under this
task order shall provide a full-service facility and staff who would support a medicinal chemistry
discovery program beginning at the Exploratory Chemistry phase to develop structure activity
relationship (SAR) analysis and design, synthesis, in vitro absorption, distribution, metabolism,
excretion and toxicology (ADMET), computational chemistry/Computer Aided Drug Discovery
(CADD) and compound logistics of storage and shipping to support the Contributor Florio
(Anagin) to develop a novel therapeutic effective in stroke. This will be achieved by advancing
the SAR/SPR of their small molecule heterocyclic starting compound utilizing their assays and
in vitro ADMET to identify novel, selective inhibitors of the target enzyme that are directed at
ischemic stroke. The scope of this Medicinal Chemistry Support Program (MCSP) task order
shall be medicinal chemistry services under Performance Area 2: Medicinal Chemistry Support
in support of preclinical drug discovery efforts supported by NIH, NINDS and its Contributors
(as outlined in the Parent SOW).

Public health relevance
Develop a novel therapeutic effective in stroke